Lifestyle Change Implementation Research Network at PRC at UMass Chan

PROJECT SUMMARY/ABSTRACT
This application in response to Special Interest Project (SIP) 25-004 will establish a Lifestyle Change
Implementation Research Network (LCIRN) Collaborating Center (Component A) and the Coordinating Center
(Component B) at the Prevention Research Center at UMass Chan Medical School. The proposed Collaborating
Center project will examine the effectiveness and implementation of a commercially available lifestyle change
intervention (LCI), Noom, among patients using GLP-1s. GLP-1s have become the new standard of care in
weight, type 2 diabetes, and cardiovascular disease management. Clinical guidelines recommend physical
activity and dietary-focused LCIs to augment GLP-1s and mitigate side effects. Noom, the first CDC-recognized
digital LCI, provides an LCI specific to the needs of GLP-1 users. However, its effectiveness and implementation
have yet to be examined. The Collaborating Center project has two aims. In Aim 1, we will conduct a randomized
controlled trial of patients using GLP-1s comparing a 4-month digital LCI (n=110) with standard of care (n=110).
Primary outcomes include change in moderate-to-vigorous physical activity and Health Eating Index score.
Secondary outcomes include frequency of muscle strengthening activities, self-efficacy for exercise and diet, as
well as lean body mass, weight, waist circumference, and blood pressure. In Aim 2, we will examine multi-level
implementation outcomes with patients, LCIs, providers, and healthcare systems. Guided by the PRISM
framework, we will use mixed methods to examine reach, implementation, maintenance, and parity of LCI
implementation. In response to Component B, the proposed Coordinating Center is designed to provide an
efficient, effective infrastructure that will grow, support and continuously improve a vibrant research network. The
network will collectively work to address critical gaps in implementation research of LCIs and implementation of
LCIs in real world practice. Aim 1 is to establish and maintain the administrative structure for the LCIRN
Coordinating Center and Network. This includes units devoted to Administration and Network Coordination,
Communications, Capacity Building, Dissemination and Translation and Evaluation. Aim 2 is to establish a broad,
engaged, multi-sector LCIRN membership. We will deploy an intensive, multi-faceted membership drive and
provide a versatile membership structure that supports member engagement. Members will be implementers,
researchers, payors and other interest holders. Aim 3 is to establish and maintain network-wide activities that
build capacity and offer other opportunities for members, partners and the broader field. We will deploy a robust
Communications Plan for all members and will support four Communities of Practice (COPs) that provide more
in-depth opportunities for capacity building and co-learning in four topic areas: (1) LCI Factors, (2) Patient-Level
Factors, (3) Health Care Providers and Systems, and (4) LCI Implementation. Aim 4 is to support the LCIRN
Coordinating Centers and build cross-site networking and collaboration. Our work will be informed by Annual
Action, Dissemination and Translation and Evaluation Plans.

Public health relevance
PROJECT NARRATIVE This proposal supports the Lifestyle Change Implementation Research Network (LCIRN) Collaborating and Coordinating Centers at UMass Chan Medical School’s Prevention Research Center. The Collaborating Center will test a technology-assisted lifestyle intervention for patients with obesity, diabetes, or cardiovascular disease who are prescribed GLP-1 medications. The Coordinating Center will establish LCIRN as a nationwide network to advance research and practice, promoting sustainable, evidence-based lifestyle interventions and reductions in obesity, diabetes, cardiovascular disease and other chronic conditions.